NIDDK Multidisciplinary Predoctoral Training in Discovery and Translational Research

PROJECT SUMMARY/ABSTRACT
This is a new application for multidisciplinary predoctoral training in discovery and translational research at
Mayo Clinic in the inter-related fields of Diabetes and Metabolic Disease, Digestive Diseases and Gastroenter-
ology, and Kidney Disease and Hypertension (DDK). The overarching objective is to develop a diverse pool of
well-trained biomedical career scientists with the experience and skillsets to become leaders in the next gener-
ation of DDK researchers. Two senior and accomplished Mayo scientists with an extensive background in
graduate education and mentoring will co-direct this program centered upon four Mechanism-Centric Research
Communities in i) Bioengineering and Biophysical Analysis, ii) Cell-to-Cell Communication, iii) Genomic Regu-
lation, and iv) Intracellular Signaling, with 24 interdisciplinary faculty members and over $20 million in funding.
This core DDK faculty provides a robust infrastructure with a successful history of training career scientists in
discovery-based and translational biomedical research. These laboratories offer a rich mentoring and training
environment that is uniquely tailored to the individual student while also promoting collective experiences
across multiple disciplines. The program's Specific Aims focus on fundamental aspects of reproducible and
rigorous biomedical research that align with NIH/NIDDK priorities. These are to: i) Offer a solid foundation in
scientific reasoning, research design, rigor, quantitative experimental approaches and analysis of datasets,
with objective interpretation of results; ii) Foster broad multidisciplinary understanding combined with critical
independent thinking skills, while implementing the ability to identify outstanding biomedical questions and ini-
tiate new approaches to advance the field; iii) Develop effective oral and written communication skills across
diverse audiences; iv) Promote ethical conduct in biomedical research and team skills that facilitate collabora-
tive scientific research alongside colleagues while promoting an inclusive work environment; v) Provide the
background to identify and effectively transition into productive basic and clinical DDK investigators. The pro-
gram strongly supports synergistic interactions between Mayo Clinic Basic Science Departments and NIDDK-
funded Centers in Digestive Disease, Translational PKD, and Pathobiology of the Enteric System. The stu-
dents will actively engage in a full array of programmatic activities, including journal clubs, seminar and works-
in-progress series, career and professional development events, annual retreat, Mayo Graduate School wide
symposium and poster session, along with participation in national meetings and others. These activities syn-
ergize with three related DDK postdoctoral programs at Mayo Clinic in Diabetes and Metabolism, Digestive
Diseases, and Kidney Disease, while offering a complete continuum from summer undergraduate research
experiences through PhD and postdoctoral training. Requirements for completion of the PhD degree conform
to Mayo Graduate School requirements, including a first author publication. The program draws from a strong
pool of 75+ qualified Mayo Clinic graduate students; we request support for six predoctoral trainees per year.

Public health relevance
PROJECT NARRATIVE Developing the next generation of career biomedical scientists is essential for the successful pursuit of new treatments for diabetes, digestive, and kidney diseases; support through this new predoctoral training grant at Mayo Clinic will assist in attaining this goal.